Community Engagement Core

Community Engagement Core (CEC) ABSTRACT
The residents of communities located along the Galveston Bay/Houston Ship Channel (GB/HSC) region have
been shown to have excess risk of exposures to hazardous substances as a result of various environmental and
anthropogenic disasters. In addition to the physical and environmental vulnerabilities, many of the residents of
these communities are also socially vulnerable. Community engagement can provide a link between the adaptive
capacities of a community—the human, financial, political, and social resources that enable proactive behavior
and the combined strength of local plans and policies—and its responses and changes after disasters. An
engaged community has greater resilience and is better able to anticipate future threats and prepare for and
recover from adverse events. The Texas A&M University Superfund Research Center is focused on
development, application, and translation of a comprehensive set of tools and models that will aid in mitigating
the human health consequences of exposures to hazardous substances during environmental emergency-
related contamination events. Accordingly, the Community Engagement Core (CEC) will develop, test and
implement a set of data-driven community engagement projects focused on fostering local resilience through
disaster research response activities. Work in the CEC will be based on locally-driven needs and grounded in
exposure science and multidisciplinary environmental health research. The CEC is working in close partnership
with a large number of local organizations, planners, other stakeholders, and residents. Specifically, we will
pursue four community engagement aims: 1) Engage community members to determine the factors that
influence and can improve environmental conditions for communities to proactively plan and manage future
environmental risk related to emergency contamination; 2) Develop collaborative, participatory-based
interventions aimed at reducing exposure during environmental emergencies; 3) Develop and implement citizen
science tools for community engagement to reduce the amount and toxicity of hazardous substances; and 4)
Build long-term resilience in the communities by creating capacity for detection, assessment, and evaluation of
the human health concerns from hazardous substances. The activities proposed under each Aim are aligned
with existing, and well-documented, stakeholder priorities and build on prior work done with community partners.
Further, the prevention/intervention activities in the CEC specifically support Superfund’s fourth mandate which
includes "basic biological, chemical, and physical methods to reduce the amount and toxicity of hazardous
substances” through the development of evidence-based strategies and an emphasis on neighborhood-scaled
green infrastructure provisions to increase resilience and mitigate hazard and contamination impacts. The CEC
will involve community partners in the entire cycle of activities, from study design, to data collection, developing
resilience strategies, communication of the findings to all stakeholders, and assistance with implementation.

Public health relevance
Community Engagement Core NARRATIVE The residents of communities located along the Galveston Bay/Houston Ship Channel (GB/HSC) region have excess risk of exposure to acute pollution, emergency chemical spills and incidents, and high-impact natural disasters, such as hurricanes and flooding. Community engagement provides a link between the adaptive capacities of a community—the human, fiscal, political, and social resources that enable proactive behavior— and its responses and changes after disruptions, including natural disasters and environmental contamination events. An engaged community has greater resilience and is better able to anticipate future threats and prepare for and recover from adverse events.